Estrogen's Neuroprotective Effects on the Brain-Barrier in Restrictive Eating Disorders

PROJECT SUMMARY/ABSTRACT
Restrictive eating disorders (R-EDs) are among the most lethal psychiatric illnesses and common in
adolescence. The proposed K23 resubmission will increase our understanding of the brain barrier in R-EDs
and test a novel therapeutic target (estrogen) as a neuroprotective moderator of brain barrier functioning,
ultimately leading to improved clinical outcomes in R-EDs. My epidemiological research demonstrates that
widespread immune dysregulation is prevalent in R-EDs. Estrogen deficiency is common in R-EDs (~60%) and
may drive neuroinflammation in R-EDs due to the neuroprotective effects of estrogen on the brain barrier. It
remains unclear whether central nervous system (CNS) inflammation (e.g., neuroinflammation) is present in R-
EDs, and whether therapy directed at a novel CNS target has beneficial effects on inflammation in R-EDs This
K23-Patient Oriented Research Career Development award application uses an innovate translational
neuroscience approach to examine the impact of estrogen deficiency and replacement on inflammation, brain-
barrier functioning, and core symptoms of R-EDs. By leveraging an ongoing R01 investigating the clinical utility
of 12-weeks of estrogen replacement in hypoestrogenemic females with R-EDs, we will evaluate the influence
of estrogen replacement (vs. placebo) on inflammation markers (Aim 1), the brain barrier – measured using
non-invasive neuroimaging to characterize volume, perfusion, and brain parenchyma extracellular water (Aim
2), and core eating disorder symptoms (Aim 3). The training aim corresponding to this project will support Dr.
Lauren Breithaupt in becoming an independent translational scientist with a program of research examining
neuroinflammation in eating disorders to identify novel therapeutic treatment targets. Each aim of the study
corresponds to a specific training goal, which will map onto three main areas of competency for Dr. Breithaupt :
(1) advanced clinical neuroscience principles, (2) non-invasive imaging of brain barrier functioning, and (3)
psychoneuroimmunology. Training goals will be implemented under the guidance of Drs. Kamryn Eddy
(primary mentor), Marek Kubicki and Madhusmita Misra (co-mentors), Cynthia Bulik, Marco Loggia, Steven
Arnold, David Alsop, Beth Stevens, (scientific advisors), and Diego Pizzagalli (collaborator).

Public health relevance
Project Narrative Estrogen deficiency is common in R-EDs, which may drive neuroinflammation given the anti-inflammatory effects of estrogen on the brain barrier. This study will use a randomized controlled trial of physiological estrogen to study the impact of estrogen deficiency (and replacement) on the brain barrier and inflammation in R-EDs. The resulting data will greatly increase our understanding of neuroinflammation in R-EDs and facilitate development of novel therapeutic targets.